Novel mechanisms of regulating endoplasmic reticulum homeostasis in alcoholic pancreatitis

Project Summary
Alcohol abuse is a major risk factor in initiating pancreatitis in humans and in rodents. However, only less than
10% of heavy drinkers develop alcoholic pancreatitis whereas most heavy drinkers have mild and autolimited
pathological changes, suggesting that a refined adaptation in pancreatic cells to protect against the detrimental
effects of alcohol. Pancreatic exocrine acinar cells possess high protein synthetic rates to produce and secrete
large amounts of digestive enzymes. To meet the high demand of protein synthesis, acinar cells are
exceptionally enriched with endoplasmic reticulum (ER). Dysregulation of ER homeostasis can lead to ER
stress and acinar cell damage resulting in the onset of pancreatitis. Cells use protective mechanisms such as
autophagy to balance the homeostasis of organelles such as ER to adapt and protect themselves from ER
stress. Defective basal autophagy in mouse pancreas disrupts ER homoeostasis resulting in ER stress and
spontaneous pancreatitis. We recently demonstrated that transcription factor EB (TFEB) directly regulates
lysosomal biogenesis and, indirectly, autophagy, which is impaired by alcohol causing alcoholic hepatitis and
pancreatitis. Our preliminary studies showed that alcohol feeding decreased VMP1 (vacuole membrane protein
1), an ER-resident multispanning transmembrane protein, at both mRNA and protein levels in an experimental
alcohol pancreatitis mouse model. More importantly, acinar cell-specific deletion of VMP1 in mice leads to
increased ER stress and spontaneous pancreatitis. Damaged and excess ER can be removed via selective
autophagy, termed as ER-phagy, which helps to maintain ER homeostasis and relieve ER stress. Our long-
term goal of this proposal is to understand the molecular mechanisms for how alcohol decreases VMP1 in
acinar cells and how VMP1-mediated autophagy protects against alcohol-induced pancreatitis. The objective of
this proposal is to understand how VMP1-mediated ER-phagy is impaired by alcohol in acinar cells and how to
pharmacologically maintain acinar cell ER homeostasis to protect against alcohol-induced pancreatitis. We will
determine how genetic and pharmacological activation of TFEB-VMP1-mediated ER-phagy regulates ER
homeostasis and protects against alcohol-induced pancreatitis. This proposal will establish a foundation for the
development of novel therapeutics for treating alcoholic pancreatitis through modulation of VMP1-mediated
ER-phagy to maintain acinar cell organelle homeostasis.

Public health relevance
Project Narrative Alcohol abuse and consumption are major causes of pancreatitis, a desperate condition with high morbidity and mortality and no specific treatment is available. Alcohol consumption disrupts acinar cell endoplasmic reticulum (ER) homeostasis resulting in increased ER stress, cell death and pancreatitis. Elucidating the molecular mechanisms of how pharmacologically and genetically improves ER quality control and homeostasis disrupted by alcohol will help to develop novel therapeutic strategies for treating alcoholic pancreatitis.